Core D: Data Management and Statistics Core

Data Management and Statistics Core
Core Leader: Sharon X. Xie; Co-Investigator: Corey McMillan
Summary/Abstract: Data Management and Statistics Core
The Data Management and Statistics (DMS) Core is an integral part of this P01 Program Project Grant (P01)
“Mechanisms Underlying Heterogeneity of Cognitive Outcome in Synucleinopathy” at the University of
Pennsylvania (Penn) Perelman School of Medicine (PSOM). The goal of the DMS Core is to support the data
management, database, statistics, bioinformatics, and related computational needs of Penn P01 investigators,
as well as provide data sharing support to investigators outside the P01 and Penn. The services provided by
the DMS Core include: (a) support for data form/questionnaire design and development, database
development and management, data entry, database audit trail, database security, database backup, and
stringent data quality control procedures, (b) computing and programming support for all Penn P01 activities,
including implementation and integration of hardware and software upgrades necessary for data management
and research, routine and archival off-site backup of computing systems central to the P01, (c) biostatistical
support for all study aspects of Projects and Cores from inception to publication, including development of
study design, performing sample size and power calculations, and performing analyses of the P01 data, (d)
integration of bioinformatics and biostatistics expertise to support analysis of genomics and proteomics data,
(e) development of new statistical methodologies and extension of existing methodologies where needed for
analyses of the P01 data, (f) Implementation of data sharing between the P01 and other researchers outside
the P01 and Penn in partnership with the National Institute on Aging. Thus, the DMS Core plays an important
and significant role that is critical to the progress of research and the conduct of studies in the Penn P01, and it
will foster collaborative interactions between the Penn P01 and researchers outside the P01.